Effects of an Intervention on Shipping-Related Air Pollution and Health

ABSTRACT
Among the more than 39 million people who live near ports in the United States (U.S.) are residents of the fourth
most populous city, Houston, Texas. Houston is home to Port Houston, one of the busiest ports in the nation.
The Texas Commission on Environmental Quality (TCEQ) estimated marine vessel diesel engines contributed
more than 11,000 tons of nitrogen oxides (NOx), 300 tons of fine particulate matter (PM2.5), and 1,800 tons of
sulfur dioxide (SO2) to air basins in Harris, Galveston, and Brazoria Counties in 2014, which added to the region’s
difficulty in meeting the national ambient air quality standards for O3 and PM2.5. Concerns about potential health
effects for residents who live near ports and bear the greatest burden of ship emissions have been rising. The
overarching goal of the proposed research is to evaluate the impact of the mandatory reduction of vessel fuel
sulfur content in the North American Emission Control Area (NA ECA) that went into effect on January 1, 2015,
on air quality and health. Our overall hypothesis is that total and cause-specific (non-accidental) mortality and
hospital admissions associated with Port Houston shipping emissions exposures decreased in Harris County,
TX due to the policy and regulatory change to low sulfur fuel oil for marine vessels transiting the NA ECA. For
exposure assessment of shipping emissions, we will employ a spatially enhanced advanced source
apportionment method (Bayesian spatial multivariate receptor modeling) that incorporates spatial correlation in
multi-site multipollutant data into the estimation of source profiles and contributions, which enables the prediction
of unobserved source-specific exposures at any location, monitored or not, and significantly reduces spatial
misalignment errors. Our objectives are three-fold. First, we will estimate shipping emissions spatial fields along
with their uncertainty estimates and construct maps of latent shipping emissions over Harris County that can be
used for identifying hot spots as well as for visualizing the changes before and after the intervention (NA ECA).
Second, we will estimate the effects of the intervention along with uncertainty estimates, including effect
estimates of shipping emissions on mortality and morbidity for Harris County residents. Third, we will examine
the effects of the intervention for subpopulations of different racial/ethnic groups and by neighborhood
disadvantage, sex, and age. This proposal responds to the NIEHS mission of evaluating disproportionate risks
of diseases due to combined environmental exposures. Tangible outcomes will include temporally- and spatially
resolved source-specific air pollution surfaces due to shipping emissions and other major pollution sources that
can be adapted in future investigations both in Houston and elsewhere in the nation and used to develop targeted
interventions to mitigate health risks.

Public health relevance
PROJECT NARRATIVE Concerns about adverse health effects of shipping emissions have been rising globally. The overall objective of the proposed study is to evaluate the impact of a policy/regulatory intervention to reduce shipping emissions on air quality and public health (i.e., total and cause-specific mortality and hospital admissions) using innovative Bayesian spatial multivariate receptor modeling, a causal inference method based on the concept of counterfactual outcomes and a strong study design that addresses issues of bias resulting from spatial misalignment and unmeasured confounding due to non-marine sources. We will also evaluate potential differences in the impact of the intervention among groups based on race/ethnicity, neighborhood disadvantage, sex, and age.